Home Health, ADRD, Telehealth, and Patient Outcomes

PROJECT SUMMARY/ABSTRACT
Close to 40% of home health patients have been identified as persons with Alzheimer’s Disease or Related
Dementias (ADRD). As the prevalence of ADRD in the population in general is expected to double by 2050, so
will the percent of patients with ADRD treated by home health agencies.
During the Covid-19 pandemic many home health agencies have begun using telehealth technologies,
including virtual visits and biomonitoring, to augment and partially substitute in-person, traditional care. This is
an acceleration of a trend that began over a decade earlier. A survey has found that by July of 2020, 49% of
agencies used some form of telehealth.
These two emerging trends, the expected increase in patients with ADRD on the one hand and the increased
penetration and utilization of TH by HHAs on the other, raise questions about whether the two are compatible.
Can home health care provided via telehealth to patients with ADRD be as good as the care provided to these
patients in person? Would it be comparable in terms of patients’ health outcomes and patients’ experience?
These questions have not been addressed to-date.
Furthermore, there is no information about the type of agencies that adopted telehealth, and in particular
among those agencies that care for a majority of ADRD patients. There is also no information about the
differences in types of telehealth technologies (e.g. communication telehealth versus biomonitoring) that were
adopted.
This study will address these questions by: 1.) performing a national survey of home health agencies caring for
a majority of patients with ADRD about their telehealth capabilities and use, and the timing of telehealth
adoption; 2.) linking survey data to agency characteristics, patients’ health outcomes and patients’ experience
data; 3.) analyzing the data statistically to identify agency characteristics associated with different stages of
telehealth adoption, the association between telehealth and better patients’ health outcomes and experiences,
and the relative ranking of specific telehealth technologies in terms of their association with better patients’
health outcomes and better patients experiences.
The information gained in this study will inform home health patients and families, advocates, the industry and
CMS, as the issue of payment for telehealth services for home health is moving forward towards consideration
by Congress and will influence federal and state policies in the coming years.

Public health relevance
PROJECT NARRATIVE This project will contribute information to the evidence base about: 1.) whether telehealth can improve health outcomes and experiences for patients with ADRD; 2.) whether all types of telehealth technologies are equally important in improving health outcomes and experiences for patients with ADRD; and 3.) which agencies are most likely to adopt telehealth.